Enhancing Maternal and Birthing Outcomes and Reproductive HeAlth through Community Engagement (EMBRACE) Center

There are longstanding adverse maternal and reproductive health outcomes in the US that have increased over time. Researchers, community leaders and clinicians are increasingly advocating for and innovating approaches that center and empower the community’s lived experience. The Enhancing Maternal and Birthing outcomes and Reproductive HeAlth through Community Engagement (EMBRACE) Center is a multidisciplinary community-academic partnership to advance maternal and reproductive health in Allegheny County, Pennsylvania, and augment training in community-informed health approaches for care providers, researchers, and policy advocates. Leveraging existing and developing relationships, as well as our leadership expertise, the EMBRACE Center consists of a key research project related to integration of enhanced postpartum (4th trimester) and interconception care given the high rates of pregnancy-associated and pregnancy-related health complications in our region. Two components (Community and Training) will provide support and structure across the Center to ensure community partnership and thought leadership in all phases of the work and training and capacity building for community-centered care. In line with the Center’s vision, researchers and community collaborators will employ power-sharing approaches. We expect the work of EMBRACE to result in sustainable methods and interventions that will advance maternal health and well-being.

Public health relevance
The EMBRACE Center of Excellence seeks to advance reproductive and maternal health f in Allegheny County, Pennsylvania via multidisciplinary, community-centered research and training. Academic partners, practitioners and community leaders will work together to implement multi-level research projects, supported and structured by components that prioritize community ownership, data transparency, and praxis for communities at risk for maternal mortality and morbidity. The intervention and implementation research generated from EMBRACE will address key factors related to maternal morbidity and mortality across the reproductive life span. Finally, EMBRACE will also set in motion necessary and sustainable improvements in academic-community partnerships, health and social services and health policy in our region.